A model system to study the tumor suppressor APC

DESCRIPTION (provided by applicant): Several key signal transduction pathways play critical roles in animal development, and also are inappropriately activated in cancer. Among these is the Wnt pathway. Its role in human cancer was first identified through the tumor suppressor Adenomatous polyposis coli (APC), mutated in most colon cancers. We now know that APC is a critical negative regulator of Wnt signaling. APC is part of a multiprotein "destruction complex" targeting the key Wnt effector _catenin for phosphorylation and eventual proteasomal destruction. Understanding APC function is essential both to understanding how Wnt signaling shapes normal development and how its inappropriate activation contributes to cancer. In addition to its role in Wnt regulation, APC also plays roles in cytoskeletal regulation. Diverse cytoskeletal functions have been ascribed to APC. Among these is a proposed role in chromosome instability in APC mutant tumors, via effects on chromosome segregation. We established a model system to study APC function in Wnt signaling and cytoskeletal regulation during normal development and to model how its inactivation leads to cancer. We use the fruit fly Drosophila, making use of the powerful combination of genetic, cell biological and biochemical tools available in flies. Both mammals and Drosophila have two APC family members, which all share a core set of protein domains but which differ at their N- and C-termini. In the past funding period, we addressed several key questions in the field. First, we discovered that the two fly APC family members act redundantly in Wnt signaling in many tissues, despite their divergent structures and striking differences in intracellular localization. Second, we generated a null allele of APC2. Using existing null alleles of APC1, this allowed us to create, for the first time, both tissues and whole animals null for both APC family members, revealing the null phenotypes of APC function in both Wnt and cytoskeletal regulation. We also generated a series of new APC2 alleles;among other findings these revealed that the truncated APC proteins characteristic of colon tumors are reduced for Wnt regulation but not null, supporting the "just right" hypothesis. They also revealed that these truncated proteins have dominant negative effects on the cytoskeleton but not in Wnt signaling. Despite the great interest in APC, key questions remain regarding its roles in the destruction complex and cytoskeletal regulation. We propose 3 Specific Aims, each addressing key questions: Aim 1: Define the mechanism(s) of action of APC proteins in the destruction complex. Aim 2: Determine how APC structure influences the assembly and activity of the destruction complex and regulates _catenin transfer to the E3 ligase Aim 3: Explore mechanisms by which APC family proteins regulate the cytoskeleton PUBLIC HEALTH RELEVANCE The body's cells communicate with one another during normal development of an embryo, and in adult tissues to regulate tissue maintenance and repair wounds. Altered cell communication underlies several common cancers including colon cancer, while loss of cell communication causes some forms of congenital bone malformation. We have developed a model system to explore how the tumor suppressor APC normally regulates cell communication and cell behavior, to allow better understanding of what goes wrong in human disease.